Preclinical Optimization and Design for Manufacturability of Immunoregulatory TEVGs

PROJECT SUMMARY/ABSTRACT
Despite the emergence of a few companies in recent years based on the clinical translation of small diameter
tissue-engineered vascular grafts (TEVGs), the gold standard for arterial bypass in the clinic continues to be
autologous vein or artery grafts. Our team has developed, with previous NIH funding (including NHLBI
Catalyze R61 funding), TEVGs based on the documented pro-regenerative immunoregulatory potency of
mesenchymal stem/stromal cells (MSCs). MSCs are immunoregulatory in that they recruit host neutrophils and
macrophages via secreted factors and modulate the recruited cells to a tolerant and pro-regenerative
phenotype. We have also demonstrated that MSCs can stimulate the production of new functional vascular
extracellular matrix both in vitro and in vivo and that MSCs play an acute antithrombogenic role in our TEVGs.
We have also successfully tested in vivo cell-free TEVG strategies based on immunoregulatory factors
secreted by MSCs via extracellular vesicles (EVs). Data generated during the previous R61 funding has led us
to select one TEVG configuration that passed our R61 milestones with acceptable critical quality attributes
(CQAs) – a silk scaffold seeded with EVs – to proceed on to testing in the R33 phase.
Our proposed project is ideal for the R33 Catalyze grant mechanism and successful completion will lead to
a pre-IDE meeting with the FDA toward the clinical translation of our TEVG device. We will perform final in vitro
CQA analysis and in vivo validation of scaled-up, human-sized TEVGs through large animal testing for 8
weeks and 6 months. We will also address manufacturability of our TEVG device and develop regulatory and
business connections. The objectives and stringent milestones for the project are summarized below:
Objective R33.1: Evaluate our Silk+EV TEVG constructs in vitro using clinically-relevant and industry-standard
measures of performance.
Milestone R33.1: Silk+EV constructs demonstrate acceptable characteristics using in vitro CQA assessment.
Objective R33.2: In vivo evaluation of human-sized Silk+EV TEVG constructs using a sheep carotid
implantation model.
Milestones R33.2a and R33.2b: At least (a) 90% of TEVGs remain patent after implantation for 8 weeks and
(b) 80% for 6 months as carotid artery interposition grafts in a preclinical large animal model.
Objective R33.3: Evaluate the manufacturability and regulatory aspects of the Silk+EV device configuration to
prepare for pre-submission meeting with FDA.
Milestone R33.3: IP protections secured, market analysis and business plan completed, data and paperwork in
hand for pre-submission meeting with the FDA, and optimal, reproducible manufacturability of our TEVG.

Public health relevance
NARRATIVE Despite great initial promise for sufferers of coronary and peripheral vascular disease, the product development pipeline has not yet produced a vascular graft that can replace the decades-old practice of harvesting blood vessels from the patient’s chest or leg to use as bypass grafts. In the proposed work, we will rigorously analyze our novel bypass graft for manufacturability and evaluate it based on implantation in large animals. We will then work with experts to address FDA, manufacturing, and business challenges to get the new graft solution through to the clinic.